Technology Identification and Training Core

The overarching goal of the proposed Penn Artificial Intelligence and Technology (PennAITech)
Collaboratory is to identify, develop, evaluate, commercialize, and disseminate innovative technology for
monitoring aging adults and those with Alzheimer’s Disease (AD) and Alzheimer’s Disease Related Dementias
(ADRD) in their home environment and the artificial intelligence (AI) methods and software for analyzing data
generated by those technologies. The Technology Identification and Training Core (Core C) is proposed
here to advance the goal of the PennAITech Collaboratory by identifying new AI algorithms and technology
based on the needs of aging Americans and developing training opportunities to facilitate their adoption and use
in the pilot funding programs. To advance this mission, we have five aims. In Aim 1, we will identify AI methods
and technology to address the needs of older Americans from extant literature via combining automated natural
language processing and human expert curation. In Aim 2, we will identify AI methods and technology to address
the needs of older Americans via engaging and collaborating with stake holders and academic/industry experts.
In Aim 3, we will develop courses and training modules on AI concepts and technology for clinicians and home
care professionals and to teach AI and technology developers about the clinical and user needs. In Aim 4, we
will create a web portal and build a central resource and knowledge base for technology identification and
training. In Aim 5, we will provide AI and technology identification and training support for pilot grant applicants
and awardees to assist them with their innovative projects. We are committed to supporting the pilot funding
programs and the overall PennAITech Collaboratory for improving the health of aging adults and those with
AD/ADRD through these specific aims.

Public health relevance
Successful aging in the home can greatly improve quality of life, improve health outcomes, and reduce burden on the healthcare system. The goal of the overall project is to establish a national Collaboratory for the development, evaluation, and implementation of artificial intelligence software and new technologies to facilitate health aging in the home. The Technology Identification and Training Core (Core C) is proposed to advance the goal of the Collaboratory by identifying new AI algorithms and technology based on the needs of aging Americans and developing training opportunities to facilitate their adoption and use in the pilot funding programs.